Vaping Cessation among youth: Evaluating the feasibility and efficacy of a virtual in-person CBT and an app-based CBT4CBT

PROJECT ABSTRACT
E-cigarettes are the most popular nicotine-delivery devices used by US adolescents. Many adolescents do not
like being addicted to e-cigarettes and want to quit. However, there are no empirically validated interventions to
help them quit using e-cigarettes. We have developed an adolescent-focused smartphone-app called Kick-Nic!©
that uses an engaging, multi-media rich, and interactive cognitive-behavioral therapy platform to teach coping
skills for e-cigarette-specific triggers and support cessation. App content to address e-cigarette appeal, quit
motivations, and coping skills, was developed using focus group evidence from 60 adolescent e-cigarette users.
The structure, format and design of the app was developed using iterative feedback from 14 adolescents. A
feasibility pilot with 19 adolescents who used the app, indicated that it was engaging, easy to use, and useful to
support e-cigarette quit efforts. An open label pilot is testing the use of the app with engagement methods
commonly used in digital interventions that were identified by youth as important for engagement [text message
reminders & weekly in-person check-ins]; 8 high school adolescents have initiated the trial, are completing all
app sessions, weekly check-ins, and assessments with 100% retention. The current proposal will:
Aim 1: Examine the efficacy of the Kick-Nic!© App: We will conduct an RCT with 306 adolescents in high
schools who use e-cigarettes regularly (>/=1 day/week in the past month) and want to quit. Adolescents will be
randomized to the ACTIVE (Kick-Nic!© App for eight weeks, along with text message reminders and weekly
virtual check-ins, & assessments) or the CONTROL condition (assessments alone with referrals to NCI Quit
Vaping webpage). E-cigarette use will be assessed at baseline, biweekly during treatment, and end of
treatment (EOT; 8 weeks), and then at 1, 2, 3 and 6 month follow ups (FU). Salivary cotinine levels </= 30
ng/ml) will verify self-reports of abstinence at EOT and 6-month FU. We will explore changes in other tobacco
and cannabis use behaviors. Our primary outcome will be 7-day, biochemically verified, point-prevalence
abstinence (PPA) rates at 6-months, and secondary outcomes include 7-day PPA at EOT, % days e-cig free
(during treatment, at EOT, 3 and 6 mths FU) and continuous abstinence (at EOT, 3 and 6 mths FU). We will also
examine the impact of app engagement, coping skill knowledge, and baseline variables (nicotine dependence, e-cig
use frequency, sex) and other tobacco product use on outcomes. Aim 2: Identify strategies for
dissemination and implementation of the app within schools. Individual qualitative interviews with up to
50% of youth in the ACTIVE condition will examine likeability of the app and engagement methods used, how to
disseminate the app to youth in school settings. Interviews with 20 school staff/administrators will examine how
the app could be implemented and used within the school setting. Thus, this innovative proposal will support
the testing, as well as dissemination and implementation within schools, of an appealing digital app that
addresses the critical need for an adolescent-focused e-cigarette cessation intervention.

Public health relevance
PROJECT NARRATIVE Over 2 million adolescents use e-cigarettes, and it is important to develop interventions to help them quit. This proposal will test the use of a novel smartphone app that uses a multi-media and interactive format to teach coping and refusal skills and help adolescents quit using e-cigarettes.